Promoting Underrepresented and Marginalized Populations' Advancement in the Sciences (PUMAS)

PROJECT SUMMARY / ABSTRACT
The goal of our program, Promoting Underrepresented and Marginalized Populations’ Advancement in the
Sciences (PUMAS), is to increase the number of well-trained biomedical research scientists from groups that
are traditionally underrepresented in the field. We propose to do this by providing twelve summer research
opportunities in Gladstone labs for community college students from such backgrounds. When students from
underrepresented and marginalized populations (URMs) gain first-hand experience in state-of-the-art labs such
as those at Gladstone, they are more prepared for success in their pursuit of science, technology, engineering,
or math (STEM) degrees when they transfer to a four-year institution, and more likely to pursue advanced
degrees in biomedical research. This then increases the number of URMs who apply for graduate school and
diversifies biomedical research. For nine weeks each summer, the PUMAS participants are paired with a
scientific mentor at Gladstone to work on a specific research project in a number of biomedical fields including
cardiovascular disease and pulmonary diseases. They spend 75% of their time doing biomedical research,
including independent research activities, receiving one-on-one mentoring and attending laboratory meetings,
scientific lectures, seminars and journal clubs. They spend the other 25% of their time participating in
supplementary educational activities, which include a week-long biotech boot-camp and a series of professional
development workshops geared to inspire students and develop them as scientists, better prepared to pursue
undergraduate and graduate degrees in the sciences. The PUMAS program culminates with a poster session in
which students describe their research, hypotheses and findings to the scientific community at Gladstone,
allowing them to increase their self-identity as scientists. The PUMAS program recruits students who are
currently enrolled in a community college, have successfully completed at least two semesters of college-level
science courses with a lab component (chemistry and molecular biology preferred, but not required), and who
intend to transfer to a four-year institution to pursue a baccalaureate degree in STEM. We do this primarily by
marketing the PUMAS program to 27 community colleges through their science professors and directors of
programs like Mathematics, Engineering, Science Achievement (MESA) within the Bay Area. We also do wider
outreach via webinars, podcasts, career fairs and diversity conferences to reach community college students
with a strong STEM interest. We chose to focus on community college students because this population is often
overlooked and has the highest percentage of URM students both by race/ethnicity and by economic
disadvantage enrolled across systems of higher education in our state.

Public health relevance
PROJECT NARRATIVE A diversity of perspectives enriches scientific research, but unfortunately, the existing STEM/health workforce, particularly with respect to research, is among the least diverse. The Promoting Underrepresented and Marginalized Populations’ Advancement in the Sciences (PUMAS) program was conceived to address this issue by providing twelve summer research opportunities in our laboratories for community college students from groups that are traditionally underrepresented in the sciences. The program aims to increase the scientific skills, knowledge, personal confidence, and scientific networks of underrepresented college-aged youth in support of their continued education and eventual careers in STEM, particularly biomedical research and health-related fields.